Research Enhancement for BUILDing Detroit (ReBUILDetroit)

Contact PD/PI: Snyder, Katherine E.
Project Summary – Overall Core
ReBUILDetroit is a partnership between institutions of higher learning in urban Detroit, comprised of University
of Detroit Mercy (primary institution), Henry Ford College (pipeline Community College partner), and Wayne
State University (research partner). Together these three institutions host almost half the population of college
students in Detroit. The majority of our students reside in the Detroit area, are from groups underrepresented in
biomedical sciences, are Pell-grant eligible, and are first generation college goers. Our students are from
socio-economically disadvantaged backgrounds and graduate from K-12 school systems that often are not
able to provide access to skills required to succeed in college. These students, for a combination of financial
and academic reasons, are unable to complete their studies, contributing to the low six-year graduation rates.
The desire and the motivation to succeed are strong even with these challenges. The ReBUILDetroit program
provides opportunities to precisely this set of Scholars. The program selects students who demonstrate the
desire to pursue biomedical majors and careers in biomedical research. The program commences with
students entering in the summer prior to their matriculation to college. In this summer enrichment program,
ReBUILDetroit Scholars become college ready, develop a network with their fellow students at the partner
institutions and are exposed to research. The first year in the program provides them with course-based
instruction in research methods and research projects, after which they conduct research with nationally-
renowned research faculty throughout their undergraduate years. Scholars form a Learning Community and
receive peer- and near-peer mentoring, dedicated academic advising from program staff, academic coaching,
professional development opportunities, social networking, and financial support throughout their
undergraduate years. Our Scholars have made excellent use of all of these support structures and have
developed a strong sense of science-identity and belongingness. They excel academically, with greater than
90% retention from the start of the program to date as the majority of the first cohort enters the fourth (senior)
year of college. Greater than 85% are on target to graduate in not six, but in four years, with STEM majors.
They view themselves as reseachers and have won awards at national conferences for presentations on the
outcomes of their research conducted with faculty. The majority of the first cohort is in the process of applying
to graduate and professional schools as they seek graduation in May 2019. Importantly, they have developed a
strong sense of belonging and have formed a network of their peers, both with their ReBUILDetroit colleagues
and with their BUILD colleagues across the national consortium. The program created in the first cycle will be
strengthened in the second grant cycle and continued even beyond the grant period as ReBUILDetroit scholars
become the next generation of biomedical researchers pursuing careers in various sectors.
Page 78
Project Summary/Abstract
Contact PD/PI: Snyder, Katherine E.

Public health relevance
Project Narrative – Overall Core ReBUILDetroit is designed to provide urban scholars with support to develop as future researchers using a program that delivers academic, research and professional development opportunities. Using these support mechanisms, the partner institutions of ReBUILD are creating infrastructure that will propel ReBUILDetroit Scholars to become the next generation of researchers bringing rich diversity to the practice of biomedical research in a variety of careers. Page 79 Project Narrative